Outcomes of beta blockers after myocardial infarction in nursing home residents

DESCRIPTION (provided by applicant): Background: The use of beta blockers for secondary prevention after myocardial infarction (heart attack) is supported by a solid evidence base for many ambulatory populations. However, virtually no data exist on outcomes of beta blockers in older nursing home patients, who may be particularly susceptible to adverse events from beta blockers and yield less benefit from these drugs. Aims: (1) To describe patterns and predictors of beta blocker use in older nursing home patients after myocardial infarction; and (2 and 3) to determine the impact of beta blockers on functional outcomes, rehospitalization, and death in this population. Methods: Using an observational study design that combines clinical and administrative data, the study population will comprise long-term residents in a large, national nursing home chain who were hospitalized for myocardial infarction between May 2007 and March 2010 and had not been using beta blockers prior to this event. Subjects will be followed for outcomes for 6 to 32 months after hospital discharge, comparing those who were and were not started on beta blockers after the index hospitalization. Data for this study will come from (1 the Minimum Data Set, a comprehensive database of standardized clinical assessment data that is completed at regular intervals by clinicians for nearly all nursing home residents in the United States; (2) claims data on inpatient diagnoses and services from Medicare Part A; and (3) drug utilization data from Medicare Part D and from a private nursing home chain (Manor Care), which captures drug use during periods where claims data from Part D are unavailable. Propensity score approaches and other causal inference methods will be employed to control for potential confounding in the relationship between beta blocker use and the outcomes of interest. Recognizing that no single approach can conclusively address all potential confounders, a series of estimates from related approaches will be used to converge on a clinically meaningful range of effect sizes. To further test and cross-validate results, the analyses will be repeated in two other cohorts. First, results will be analyzed for all Medicare patients nationwide who returned from hospital to nursing home without an intermediary period of post-acute rehabilitation (the period invisible to Medicare Part D). Second, analyses will be repeated for patients in VA nursing homes. VA data contain additional elements not available through Medicare, allowing testing of modeling assumptions and potential biases that can be used to refine analyses in the primary cohort. Relevance / public health significance: Better understanding the benefits and harms of beta blockers in frail nursing home residents after myocardial infarction will substantially improve the evidence base and help guide treatment decisions for this important population.

Public health relevance
PUBLIC HEALTH RELEVANCE: Better understanding the benefits and harms of beta blockers in frail nursing home residents after myocardial infarction will substantially improve the evidence base and help guide treatment decisions for this important population. __SpecificAimsTextDelimiter__ SPECIFIC AIMS T Beta blockers are mainstays of secondary prevention in adults who have had myocardial infarction (MI).1-2 1 -8 his effe ct size is within bou nds of ot her studi es of bet a block ers i n old er patie nts with MI: the maj ority of major obs erva tional studi es ha ve sh own relativ e risk red uctio ns fo rde ath of 2 1-4 0%, simila rto the 20 -36% relative risk red uction obs erve d in t he origin al ra ndo mize d trials . Randomized controlled trials have proven that long-term use of beta blockers after MI substantially reduces mortality in persons up to age 75 years.3-6 Observational studies have extended these findings to even older patients, demonstrating a similar mortality benefit in community-dwelling people up to and beyond age 85 years.7-9 Nonetheless, older patients are less likely than their younger counterparts to receive beta blockers after MI, and use of these drugs is dramatically lower still in patients who are frail.1,9-13 The cardiovascular benefits of beta blockers may well extend to these vulnerable older patients.1 So, why are prescribing rates so much lower in this group? Part of the answer lies in concern about the adverse effects of beta blockers in vulnerable elders, including harmful effects on daily functioning.14-15 There are compelling reasons why the adverse effects of beta blockers may be disproportionately common and severe in this group. Beta blockers can cause positional lightheadedness (orthostasis), worsen dyspnea in people with reactive airways, exacerbate fatigue, and more.16-17 In most patients, these adverse effects are relatively infrequent and manageable.18-19 However, the limited functional reserve of frail elders may render them less able to compensate for the physiologic perturbations caused by beta blockers, leading to more adverse events and to the transformation of minor harms into major ones.16,18,20-21 For example, in a frail elder with borderline ability to ambulate independently, the development of orthostatic symptoms may "tip them over the edge" into a state of frequent falls and impaired ability to ambulate independently. These potential adverse effects on function are critically important to vulnerable elders. Many nursing home residents and their clinicians value maintaining function and quality of life more than extending lifespan, and knowing if a drug is or is not likely to cause functional decline can and should play a key role in treatment choices. Although concerns about the functional effects of beta blockers have an important role in prescribing for vulnerable older adults, there is virtually no evidence about how beta blockers affect functional status in this population. Moreover, the potential benefits of beta blockers have not been adequately studied in these types of patients.1 Well-done research that quantifies the actual harms and benefits of beta blocker therapy in vulnerable older adults can provide evidence to help improve clinical decision-making for these patients. Results showing that beta blockers cause functional decline would validate commonly-held suspicions and provide an evidence-based framework for treatment decisions that consider outcomes of central importance to older adults. In contrast, if results show that beta blockers do not hurt (and perhaps even help) functional status, and if they confirm the ability of beta blockers to reduce mortality and rehospitalization, this would strongly challenge clinicians' reluctance to prescribe and would support efforts to increase beta blocker use in institutionalized elders. In sum, physician decisions about prescribing beta blockers to vulnerable older adults suffer from a severe lack of data on the functional harms (and potential benefits) of these drugs in this population. We propose an observational study using unique data resources and advanced statistical methods to evaluate functional and other outcomes of beta blocker use after MI in older nursing home residents. Our research can provide an evidence basis that addresses outcomes of key interest to patients and their clinicians, and in doing so can directly inform this important treatment decision. Specific aims: 1. To describe patterns of beta blocker use in nursing home residents after myocardial infarction and to characterize individual and facility-level determinants of use. a. Hypothesis: Older adults with a greater degree of functional impairment will be less likely to receive beta blockers. 2. To determine the impact of beta blockers on functional outcomes in older nursing home residents after myocardial infarction. a. Hypothesis: Beta blockers will be associated with worse functional outcomes 3. To determine the impact of beta blockers on repeat hospitalization and death in older nursing home residents after myocardial infarction. a. Hypothesis: Beta blockers will be associated with reduced rates of hospitalization and death